Novel mechanisms of age-enhanced vasculopathy after heart transplantation

Project Summary
Heart transplantation is a vital therapy for end-stage heart failure. The effectiveness of this therapy, however,
is largely limited by the shortage of donors. Regrettably, less than 40% of available heart donations are used
for transplantation and the rate of use is declining due to increasing donor age. Transplants from donors older
than 55 years of age are typically disregarded as increasing donor age is the strongest independent factor for
both mortality and the development of chronic allograft vasculopathy (CAV), the leading cause of graft loss for
organ transplants. Additionally, older donor hearts often exhibit atherosclerosis, rendering them unsuitable for
transplantation. However, the mechanisms by which donor age increases CAV remain unknown. Our prior
work demonstrates that aged murine vascular smooth muscle cells (VSMC) contribute to vascular inflammation
by producing IL-6, CCL2 and osteopontin via MyD88, an innate immune adaptor protein downstream of the
Toll like receptors. Our preliminary data also indicate that aging impairs mitophagy, i.e., the clearance of
damaged mitochondria, within VSMC to enhance vascular inflammation. We therefore hypothesize that
impaired mitophagy within aged donor VSMC leads to MyD88-dependent vascular inflammation that enhances
CAV. To test this hypothesis, we will use novel mice in which MyD88 is selectively deleted within VSMC to
examine whether MyD88 expression within VSMC of the aged donor vasculature is critical for CAV in a murine
heart transplant model (Aim 1). We will also examine whether MyD88 expression within VSMC of the aged
donor vasculature is critical for the progression of pre-existing donor atherosclerosis after cardiac
transplantation by employing a novel method to induce atherosclerosis in the donor heart prior to
transplantation. In addition, we will use young mice in which either autophagy or mitophagy is disabled within
VSMC, to determine if autophagy or mitophagy in these cells controls CAV (Aim 2). We will complement this
approach by examining if administration of agents that enhance autophagy, e.g., rapamycin or mitophagy e.g.,
actinonin, to aged donor mice reduces CAV after cardiac transplantation. We expect that our study will directly
link inflammatory pathways in the donor vasculature to CAV. Our results could lead to new therapeutics to
reduce both the development of CAV and the progression of native vessel atherosclerosis in donor hearts.
Such therapeutics could tremendously increase the pool of heart transplant donors and save lives of patients
with end stage heart failure.

Public health relevance
Project Narrative Heart transplantation utilization is limited by the size of the donor pool. One of the largest contributors to the limited donor pool is the age of heart donors: transplants from donors over 55 years of age are rarely used as this increases the development of chronic allograft vasculopathy, the leading cause of graft loss. In this proposal, we will investigate the mechanisms by which the aged donor vasculature enhances chronic allograft vasculopathy in mice, which could ultimately expand the donor pool to allow more heart transplants to be performed.